Understanding the molecular mechanisms that contribute to neuropsychiatric symptoms in Alzheimer Disease

PROJECT SUMMARY
Neuropsychiatric symptoms (NPS) are core features of Alzheimer’s disease (AD) and related dementias that are
associated with major adverse effects on daily function and quality of life, and accelerate time to
institutionalization. Of all the NPS, depression is the most frequently observed symptom in people with mild
cognitive impairment and early AD. As the disease progresses, agitation, delusions and hallucinations become
more common, whereas apathy is the most persistent and frequent NPS throughout all the stages of AD. AD-
NPS share some clinical features with serious mental illnesses (SMIs), such as schizophrenia, bipolar disorder
and major depressive disorder, but whether these conditions share similar aethiopathies is unclear. Given that
reliable treatments for NPS in the context of AD and other dementias do not exist, a better understanding of the
molecular mechanisms and pathways underlying NPS in AD and other neuropsychiatric illnesses is a critical
next step to identify reliable biomarkers that could lead to novel therapeutics.
The overarching goals of the parent grant are to: (1) identify the molecular mechanisms and neuropathological
changes that are associated with the presence of NPS in patients with AD; and (2) examine if the mechanisms
of pathology associated with NPS are shared or distinct among AD and SMIs. More specifically, we are currently
building gene regulatory networks to integrate phenomics and genomics data (genotypes, single nucleus profiles
from dorsolateral prefrontal cortex) from 1,500 autopsy cases. Detailed phenomics data such as well
characterized NPS, clinical diagnosis (AD and other neurodegenerative or neuropsychiatric traits), severity of
cognitive decline and neuropathology are being utilized. We expect that these models will enable us to assign
genotypes and molecular markers to specific NPS within AD and other neuropsychiatric traits at the single-cell
level, an unprecedented level of resolution. In addition, we will test the translational potential of the genotype-
marker-phenotype models to predict AD-NPS using independent large-scale biobank datasets, in which
genotypes and electronic health records are available.
This administrative supplement will further enhance these efforts by leveraging human brain single-cell data
generated as part of large consortia, including BICAN, SEA-AD, psychENCODE, AMP-PD, and AMP-AD, to
validate molecular mechanisms and pathways that are shared or distinct across AD and SMIs. Successful
completion of the proposed studies will have immediate utility by generating potential biomarkers for NPS
diagnosis and prognosis and by providing predictive models for patient stratification in clinical trials. In the longer
term, our models will help us create a blueprint for therapeutic strategies and interventions to treat NPS in AD.

Public health relevance
PROJECT NARRATIVE Neuropsychiatric symptoms (NPS) are core features of Alzheimer’s disease (AD) and related dementias, that contribute to early institutionalization and cause substantial caregiving and caregiver burden. In the parent grant, we utilized high-dimensional phenomics and genomics data in human brain tissue to study the molecular mechanisms and pathways underlying NPS in the context of AD and other neuropsychiatric illnesses. The overarching goal of our administrative supplement is to leverage human brain single cell data generated as part of large consortia, including BICAN, SEA-AD, psychENCODE, AMP-PD and AMP-AD, and validate molecular mechanisms and pathways that are shared or distinct across AD and serious mental illness.